ADMINISTRATION CORE

The administrative core for the program will function to facilitate central coordination of the fiscal management of the grant, and the integration of the separate research projects into a coherent whole program. Responsibilities of Core A include (1) Financial administration, (2) Budget management, (3) Coordinating administrative issues for scientific interactions (i.e., scheduling meetings, organizing seminars, assisting with collaborative manuscripts, assisting with abstract submissions and rehearsals for scientific meetings), (4) Coordinating the purchase of supplies for all projects, (5) The provision of common administrative supplies, (6) Accurate record keeping and prompt reporting to NIH, (6) Scheduling and arranging travel for External Advisor Meetings, (7) Scheduling and arranging travel for invited speakers, (8) Oversight of ethical conduct for all Program participants, (9) Coordination of institutional approval for animal, biohazard and radiation utilization, and (10) Generating and maintaining inventories of laboratory resources and technical expertise.